Precision Animal Models and Organoids Core

PROJECT SUMMARY PAMOC
The overarching mission of the WU-DDRCC is to promote collaborative, multidisciplinary research focused on
interactions between host and environment in digestive disease. The Precision Animal Models and Organoids
Core (PAMOC) evolved over the previous funding period in response to changes in members' needs, and with
the establishment of a new institutional gnotobiotic facility. These changes, along with guidance from our External
Advisory Board, encouraged us to modify the services and objectives of this Core. Accordingly, our current
objectives are to 1) assist investigators in the efficient and cost-effective development and propagation of
genetically altered mouse models to elucidate the pathogenesis of digestive diseases; and 2) assist investigators
in the culture of human and mouse gastrointestinal epithelial cell organoids to address cell biological questions
relevant to digestive diseases and host-environment interactions. Both human and mouse gastrointestinal
epithelial cells and the required media are available to DDRCC investigators for growth and differentiation of
organoids. These novel models will serve as important avenues for pre-clinical studies and enable translation of
basic research advances into clinical practice. KEY ACCOMPLISHMENTS since 2013 include: completed 24
nucleic acid injection projects (both conventional DNA transgenes and CRISPR/Cas9/targeting vector injections)
for 7 members; 3 embryonic stem cell injection projects for 2 members; and 11 withdrawals of transgenic/knockin
mice from the Mouse Bank by 9 members. Gnotobiotic services (provision of germ-free mice, rederivation to
germ-free status, and gnotobiotic conventionalization) were provided to 6 members. Related to the proposed
Organoid component, we have already distributed human cell lines as well as wild type and reporter mouse cell
lines to 13 members. We also provided L-WRN conditioned media to 9 members. Since 2013, 22 members used
the Core, resulting in 57 publications citing the WU-DDRCC. Our SPECIFIC AIMS include: (1) To assist
investigators in the generation and propagation of transgenic, knockout, and knockin mice for the study of
digestive diseases. This includes injections of nucleic acids, including CRISPR/Cas9 and TALEN reagents, into
zygotes, assistance with rederivation of lines as specific pathogen free, and in vitro fertilization. (2) To maintain
a “Mouse Bank” containing transgenic strains of use to DDRCC investigators and to provide these mice on
demand for digestive disease-relevant projects. (3) To provide banked human and mouse gastrointestinal
epithelial cell lines and the culture media required for successful growth of organoids and for growth of epithelial
cell monolayers. Support for monitoring cell growth and for imaging organoids will also be provided. (4) To
provide assistance with the derivation of new gastrointestinal epithelial cell lines from mice and humans. Aims 1
and 2 will continue to leverage the outstanding facilities, personnel, and expertise of the Washington University
Institutional Mouse Genetics Core. Aims 3 and 4 will benefit from infrastructure and expertise developed by Dr.
Ciorba and his collaborators here at Washington University.